Naltrexone and Behavioral Drug and HIV Risk Reduction Counseling in Russia

DESCRIPTION (provided by applicant): With an estimated 1.6-4 million opiate users (majority with injection drug use (IDU)) and more than 940,000 HIV infected individuals (80% linked to IDU), the Russian Federation is facing the prospect of an explosive HIV epidemic. Currently in Russia, inpatient detoxification followed by oral naltrexone maintenance (NMT) is the only pharmacologic treatment for opiate dependence. Evidence-based counseling to reduce HIV transmission and relapse following detoxification is not widely available or routinely provided. NMT is offered using a medical model, with physicians providing only brief medical management (MM). Several considerations, including data from our preliminary studies, suggest that the efficacy of NMT may be improved by using extended-release naltrexone (XR/NTX) instead of oral naltrexone (O/NTX) and by combining NMT with behavioral drug and HIV risk reduction counseling (BDRC). [By reducing adherence problems and treatment attrition, XR/NTX may improve clinical effectiveness (i.e., reduce relapse risk, IDU, and other risk behaviors associated with drug use).] BDRC may also improve medication adherence and promote behavioral change leading to reduced relapse risk, IDU, and other drug- and sex-related HIV risk behaviors. However, the efficacy and cost-effectiveness for reducing drug- and sex-related HIV risk behaviors and increasing duration of opioid abstinence of the various combinations of naltrexone formulation (O/NTX vs. XR/NTX) and counseling (MM only or combined with BDRC) have not been systematically evaluated. Consequently, we are proposing a 2x2 factorial randomized clinical trial evaluating the efficacy and cost-effectiveness of two medication formulations (O/NTX and XR/NTX) and two manual-guided counseling conditions (MM only or MM+BDRC) and the potential interactions between medications and counseling conditions. Following detoxification, opiate dependent subjects (N=320) will be randomly assigned to 6 months of treatment in one of four treatment groups: O/NTX+MM, XR/NTX+MM, O/NTX+MM+BDRC, or XR/NTX+MM+BDRC. [Primary outcome measures include reductions in sex- and drug-related HIV risk behaviors, [reductions in illicit opiate use], and treatment retention. Other outcome measures include reductions in frequency of opiate or other drug use, health status and healthcare utilization, criminal behavior and arrests, and improvements in vocational and family functioning and quality of life.] All study participants will be assessed at baseline and monthly during the 6 month treatment phase and for 6 months following the active treatment phase. Data analyses will focus on the intention-to treat sample. The study results will allow evaluation of whether XR/NTX has superior efficacy or is more cost-effective than O/NTX, whether BDRC plus MM has superior efficacy or is more cost- effective than MM only, and whether particular combinations of medications and counseling have superior efficacy or are more cost-effective than other combinations.

Public health relevance
PUBLIC HEALTH RELEVANCE: The long-term goals of this study are to foster development and dissemination of evidence-based behavioral and pharmacological treatments to reduce HIV transmission, injection drug use (IDU), and heroin use in Russia. This study will examine the effects of combining behavioral therapy with naltrexone pharmacotherapy for the treatment of opiate dependence and reduction of HIV risks in opiate dependent individuals. Specifically the study will determine whether extended-release injection naltrexone has greater efficacy and is more cost- effective than oral naltrexone maintenance, whether behavioral drug and HIV risk reduction counseling (BDRC) combined with brief, medical management (MM) has greater efficacy and is more cost-effective than MM only, and whether particular combinations of medication formulation and counseling (MM only or MM plus BDRC) have greater efficacy or are more cost-effective than other combinations. Relevance The long-term goals of this study are to foster development and dissemination of evidence-based behavioral and pharmacological treatments to reduce HIV transmission, injection drug use (IDU), and heroin use in Russia. This study will examine the effects of combining behavioral therapy with naltrexone pharmacotherapy for the treatment of opiate dependence and reduction of HIV risks in opiate dependent individuals. Specifically the study will determine whether extended-release injection naltrexone has greater efficacy and is more cost- effective than oral naltrexone maintenance, whether behavioral drug and HIV risk reduction counseling (BDRC) combined with brief, medical management (MM) has greater efficacy and is more cost-effective than MM only, and whether particular combinations of medication formulation and counseling (MM only or MM plus BDRC) have greater efficacy or are more cost-effective than other combinations. __SpecificAimsTextDelimiter__ Specific Aims With an estimated 1.6-4 million opiate users (majority with injection drug use (IDU)) and more than 940,000 HIV infected individuals (80% linked to IDU), the Russian Federation is facing the prospect of an explosive HIV epidemic. Currently, detoxification followed by oral naltrexone maintenance (NMT) is the only pharmacologic treatment available in Russia to treat opiate dependence. NMT is typically offered using a medical model, with physicians providing only brief medical management (MM) and without any additional psychosocial support services. Several considerations, including data from our preliminary studies, suggest that the efficacy of NMT may be improved by using extended-release injection naltrexone (XR/NTX) instead of oral naltrexone (O/NTX) and by combining NMT with behavioral drug and HIV risk reduction counseling (BDRC). By increasing medication adherence and reducing treatment attrition, XR/NTX may extend opiate abstinence after detoxification and reduce relapse risk and IDU. BDRC may also improve medication adherence and promote behavioral change leading to more sustained and complete recovery associated with reduced/eliminated opiate use and decreased drug- and sex-related HIV risk behaviors. However, the efficacy and cost- effectiveness of the various combinations of naltrexone formulation (O/NTX vs. XR/NTX) and counseling (MM only or combined with BDRC) have not been systematically evaluated. Consequently, in collaboration with Pavlov Medical University in St. Petersburg, Russia, we are proposing a 2x2 factorial randomized clinical trial to evaluate the efficacy and cost-effectiveness of two medication formulations (O/NTX and XR/NTX) crossed with two counseling conditions: medical management (MM) only or MM plus behavioral drug and HIV risk reduction counseling (BDRC) in detoxified, opiate dependent subjects (N=320) in St. Petersburg. The specific aims and hypotheses of the proposed study are as follows: Specific Aim 1: To evaluate the differential efficacy of NMT using O/NTX or XR/NTX when combined with MM only or MM plus BDRC. [Hypothesis 1) We hypothesize that providing BDRC in addition to MM will have greater efficacy than MM alone with regard to our primary outcome measures (reducing HIV risk behaviors, reducing illicit opioid use, and improving treatment retention) and secondary outcome measures (reducing other illicit drug use and criminal activity, improving family and vocational functioning, and quality of life). Hypothesis 2) We hypothesize that naltrexone extended release injection (Vivitrol) will have greater efficacy than oral naltrexone with regard to our primary outcome measures (reducing HIV risk behaviors, reducing illicit opiate use, and improving treatment retention). We will also evaluate the significance of the interactive effects of the two treatment factors on the primary outcome measures. However, we do not hypothesize specific effects for these interactions. We will also evaluate the treatment effects on a limited set of secondary outcomes including specific drug- and sex-related HIV risk behaviors (measured by Drug and Sex subscales of the ACASI-ARI), reductions in other illicit drug use, and improvements of functional status.] Specific Aim 2: To compare the direct, economic costs (including costs of space, labor, medications, dispensing, laboratory, as well as patient costs), and the incremental cost-effectiveness of the four study therapies (O/NTX+MM, O/NTX+BDRC, XR/NTX +MM, and XR/NTX +BDRC).